GROWTH AND ENDOCRINE AFTER RENAL TRANSPLANTATION

This project is evaluating whether endocrine abnormalities are associated with post renal transplant growth failure, which of these patient will respond to exogenous growth hormone therapy, and which factors are predictors of this growth response.